Acquisition of multi-mode, high-resolution, high-sensitivity imaging platform

Project Summary/Abstract
This application requests funds to acquire a Typhoon 5 imaging platform, urgently needed to replace and
upgrade the outdated and no longer factory-supported Typhoon 9500 in the Shared Instruments Pool (SIP) core
facility in the Department of Biochemistry, University of Colorado Boulder. The Typhoon 5 is a high-sensitivity,
high-resolution imaging platform for the imaging, characterization, and precise quantification of proteins, RNA,
DNA, small molecules, and complexes. The multimode imager includes phospho imaging for radioisotope
labeled samples, multi-color fluorescence detection (red, green, blue, and two near-infrared channels),
calorimetric densitometry, and limited chemiluminescence. It can image in many different targets, including
phospho storage screens, gels, membranes, TLC plates, multiwell plates, and microarrays. The extensive
biomolecular imaging capabilities are essential for many biomedical research programs at CU Boulder.
SIP provides a combination of cutting-edge instrumentation and well-maintained basic research
instrumentation to the CU research community. The core facility widely and positively impacts many biomedical
research programs at CU-Boulder, but this requires acquiring and maintaining advanced, state-of-the-art
instrumentation. The current Typhoon 9500 in SIP has over the last five years served 182 individual users from
31 research groups in 5 departments and institutes at CU Boulder. A core group of 12 research labs - including
10 NIH-funded groups (a total of 15 ongoing NIH-funded projects) and two early-stage investigators from three
departments - is currently relying heavily on the imaging capabilities of the Typhoon. The imager is used to
collect publishable data (e.g., activity assays, binding stoichiometry, sequencing gels, and much more) and to
quality control and optimize samples for downstream experiments. The new Typhoon 5 will serve existing
biomedical research projects and will add new capabilities with two additional fluorescence channels in the NIR
for increased sensitivity and improved signal-to-noise for challenging samples.
The new Typhoon 5 in SIP will be available to all research groups at CU Boulder supported by the well-
established management and financial structure that has served SIP and its research community well for the last
10 years. SIP staff will offer expertise and aid from experiment design to training, data collection, troubleshooting,
and data analysis. This strong support structure empowers new and existing users to conduct pilot studies to
test new experiments and research projects. It increases the success rate and minimizes the financial burden
for research groups. This is essential for the future of biomedical research and will positively impact many new
research programs at CU Boulder from innovative, basic research seeking to understand the fundamental
mechanisms that govern human life and health (e.g. gene regulation, cell signaling, membrane biology, aging,
and more) to translational research, for example, developing new drug targets, new therapeutic small molecules,
antimicrobials, and drug delivery methods.

Public health relevance
Project Narrative The proposed Typhoon 5 is a workhorse, biomolecular imager for imaging and precise quantification of proteins, DNA, RNA, and small molecules in membranes, gels, and plates using fluorescence, radioactivity, or calorimetric densitometry with exceptional sensitivity and resolution. The instrument will replace the outdated older generation Typhoon 9500 in the Shared Instrumentation Pool (SIP) Core Facility of the Biochemistry Department at CU Boulder, which gives the wider CU research community access to an extensive, excellent biomedical research infrastructure. The new imager will ensure continued access to essential and fundamentally needed quantitative imaging capability for at least 15 strong, ongoing NIH funded biomedical research projects and enable new groundbreaking research projects including but not limited to nucleic acid biochemistry, RNA structure and function, mechanisms of transcription and DNA replication, signal transduction and cell cycle regulation, membrane protein research, structural biology, and the development of therapeutic small molecules, proteins, and antimicrobials.